Novel high-throughput in vivo approach to define pathobionts driving colitis

ABSTRACT
Patients with Inflammatory Bowel Diseases (IBD) experience chronic intestinal inflammation as
a consequence of inappropriate immune responses to the microbiota. Patients with IBD,
particularly Crohn’s disease (CD), are at a greater risk of developing co-morbidities including
intestinal fibrosis/stricturing and IBD-associated colorectal cancer (CRC). These diseases can
be driven by specific strains of Escherichia coli. The CD and CRC microbiomes harbor high
loads of mucosal E. coli described as “adherent-invasive E. coli” (AIEC). AIEC have no genomic
definition, but instead are distinguished by functional attributes tested through exhaustive in vitro
co-culture assays: the ability to adhere to and invade cultured epithelial cells and replicate and
persist in macrophages. Our preliminary data indicate that this in vitro AIEC definition may not
predict in vivo mucosal colonization, and that specific taxa expand with E. coli and contribute to
inflammatory disease. The objectives of this proposal are to thoroughly interrogate the AIEC
definition in vivo, define microbiome compositional changes driven by high levels of E. coli in
colonic and ileal tissues, and identify candidate factors harbored by E. coli that permit
colonization of the inflamed intestine. To this end, we have developed a polymicrobial
colonization strategy that uses a novel barcoding technology to easily distinguish genetically
similar, but functionally distinct sub-strains of clinical E. coli in a complex community. We have
developed this strategy using a collection of well-characterized clinical AIEC and non-AIEC
strains isolated from the intestinal mucosa of CD and healthy patients. This novel approach
overcomes technological limitations associated with profiling bacterial metagenomes intimately
associated with host tissues using molecular barcoded bacterial strains, gnotobiotic mouse
models well-established in our lab, and barcode-targeted high-throughput sequencing and
genomics. This innovative approach positions us to comprehensively interrogate the AIEC
definition and identify molecular features required for colonization of the inflamed intestine. We
must understand what microbial features promote mucosal colonization with high-risk E. coli
strains in order to identify IBD patients at risk for a complicated disease course.

Public health relevance
NARRATIVE Inflammatory bowel diseases (IBD) are associated with an increase in adherent-invasive Escherichia coli (AIEC), which are defined by functional attributes and have no known molecular signature that can be used for screening and identification. We have developed a novel high-throughput sequencing approach to thoroughly interrogate the AIEC definition based upon their ability to colonize in a relevant mouse model. Our project will define distinguishing molecular features of AIEC and allow us to identify individuals harboring high-risk E. coli strains that drive disease.